The fertility, maternal health, and infant health consequences of reproductive policy change

PROJECT SUMMARY
The Dobbs v. Jackson Women’s Health Organization Supreme Court decision, which eliminated federal
protections for abortion rights, is an unprecedented policy change with implications for fertility, maternal health,
and infant health in the US. Abortion is currently banned in 12 states and severely restricted in 14 others.
Approximately one in three people who can become pregnant in the US reside in a state with little or no access
to safe abortion services since the ruling, predominantly in the South and Midwest, where a disproportionate
share of the population is Black or Hispanic. Restricting safe abortion services may differentially impact fertility
rates of disadvantaged groups, with long term implications for population health and persisting disparities.
Populations with the highest abortion rates are also at greater risk of poor pregnancy and birth outcomes,
including late entry into prenatal care, preterm birth, low birthweight, and severe maternal morbidity. Abortion
restrictions imposed following Dobbs may increase rates of negative pregnancy outcomes and widen
disparities simply because more people who reside in those states, especially disadvantaged populations, are
exposed to the risks associated with carrying a pregnancy to term. Post-Dobbs abortion restrictions may also
directly impact risks of these outcomes via changes in clinical practice, accessibility of timely maternal care,
and increases in stress. The proposed research will estimate the impact of the Supreme Court’s Dobbs
decision on fertility and maternal and infant health outcomes over time and by subgroups in states that recently
banned or restricted abortion services. We will use high-quality, state-specific monthly data from 2016 through
2024 from several sources, including state birth certificate data compiled nationally by the CDC, Census
Bureau data, and administrative hospitalization data from State Inpatient Databases. For each Aim, we will
estimate the impact of Dobbs on outcomes using a comparative interrupted time series design with control
locations, establishing a strong counterfactual to support causal inference while also accounting for recent
trends (e.g., declining fertility) and perturbations (e.g., COVID-19). For Aims 2 and 3, we will use a difference-
in-difference decomposition approach to determine how much of the observed change in outcomes post-
Dobbs is attributable to shifts in the composition of the birthing population versus changing risks, comparing
restrictive and non-restrictive states. We propose the following specific aims: 1) Evaluate the impact of the
Dobbs decision on fertility; 2) Determine the impact of the Dobbs decision on severe maternal morbidity; 3)
Assess the impact of the Dobbs decision on infant birth outcomes, including preterm birth, low birthweight, and
small for gestational age. This work will address major gaps in the literature regarding the causal impact of
abortion restrictions on population health, in particular post-Dobbs abortion restrictions, for which we currently
have limited knowledge. This research will also determine how anti-abortion policies may especially harm
disadvantaged populations and produce time-sensitive results to inform reproductive health policies in states.

Public health relevance
PROJECT NARRATIVE The Dobbs v. Jackson Women’s Health Organization Supreme Court decision, which overturned a half century of legal precedent that protected the right to induced abortion, is a landmark policy change with implications for fertility, population health, and related disparities in the US. The proposed research will use a comparative interrupted time series design to estimate the impact of the Dobbs decision on fertility and maternal and infant health outcomes over time and by subgroups in states that recently banned or restricted abortion services. This work will address major gaps in the literature regarding the causal impact of abortion restrictions on population health, in particular post-Dobbs abortion restrictions, for which we currently have limited knowledge, and produce results that can inform time-sensitive reproductive health policy decision making in states in the coming years.